Vet-LIRN Network Capacity Building for SARS-CoV-2: equipment for analysis of NGS library and data

Project Abstract
The University of Illinois (UI) Veterinary Diagnostic Laboratory (VDL) is a full service, AAVLD accredited, all
species, reference laboratory. UI VDL is a member of the VET-LIRN. As of Feb 17, 2023, UI VDL has tested
3,287 samples for SARS-CoV-2 and 350 samples of zoo animals in 13 different zoos were tested positive. Next-
generation sequencing (NGS) is very useful in case investigation of SARS-CoV-2 in the veterinary diagnostic
laboratory and could be affected by many factors including selection of sequencing methods, sequencing library
quality, amount of viral genome, sample quality, sample pooling, and bioinformatics analysis. New equipment
for analyzing both NGS library and big data will significantly increase our SARS-CoV-2 testing capacity and
service quality for routine case diagnosis and surveillance coordinated by Vet-LIRN, thus enhancing Vet-LIRN
network laboratory for SARS-CoV-2 testing.

Public health relevance
Public Health Relevance Statement: Project Narrative The purpose of this proposal is to get support to purchase new equipment for analysis of NGS library and big data to increase UI VDL testing capacity for SARS-CoV-2. This project will provide enhanced capacity for FDA Vet-LIRN routine case diagnosis and surveillance assignments of SARS-CoV-2 in animals.